Investigating the Benefits of Remotely-supervised Neuromodulation in Primary Progressive Aphasia

Project Summary/Abstract
The logopenic variant of primary progressive aphasia (lvPPA) is a disorder characterized by gradual decline in
language abilities that is typically caused by underlying Alzheimer’s Disease (AD) pathology. The impact of
lvPPA on people’s communication lives is profoundly devastating. It can emerge in adults as young as their 50s,
stripping them of their ability to communicate and function and affecting their careers, their family roles, and their
potential to enjoy the rewards of mid-to-late life. Although lvPPA and other disorders on the AD and other AD
Related Dementias (AD/ADRD) continuum are now identified earlier and with greater precision, research
investigating interventions to ameliorate lvPPA’s debilitating effects on communication, prolong language skills,
and maximize quality of life lags significantly behind. There is a critical need for rigorous investigations of
behavioral and neuromodulatory treatments capable of leveraging spared brain areas for functional
improvement, specifically for people with lvPPA, who are underrepresented in treatment research. Failure to
meet this need means that people with lvPPA and their families are more likely to face an increased disability
burden earlier and for a longer period than is necessary. To date, the field has relied on laboratory-based
neuromodulation protocols developed for healthy aging and stroke-induced aphasia populations. This approach
has prevented development of intervention models aligned with lvPPA functional needs and neurobiological
factors, delaying vertical progress in much-needed nonpharmacological interventions. The overall objective of
this project is to enhance the potency of proven language treatment for lvPPA by pairing it with tailored and
accessible (home-based) neuromodulatory intervention that targets critical brain networks supporting effective
intervention in this population. The central hypothesis is that such an approach will be feasible, acceptable, and
show evidence of clinical benefit. Guided by strong preliminary data, two specific aims will be pursued: 1)
Evaluate the feasibility, acceptability, and preliminary benefit of remotely-supervised transcranial direct current
stimulation (RS-tDCS) and virtual speech-language treatment (vSLT) in persons with lvPPA and 2) Identify
neural and electrical field factors that predict responsiveness to RS-tDCS in persons with lvPPA. To accomplish
these aims, 80 individuals with lvPPA will undergo comprehensive cognitive-linguistic and neuroimaging
assessment and RS-tDCS (active or sham) in conjunction with language telerehabilitation. This project’s
contribution will be significant because of its broad application to individuals with other disorders on the AD/ADRD
continuum who have historically been underserved by rehabilitation specialists and who would benefit from
innovative treatments to prolong independence and quality of life.

Public health relevance
Project Narrative This project is relevant to public health because it aims to optimize treatment for communication impairments associated with the logopenic variant of primary progressive aphasia, a debilitating, language-prominent form of dementia. The project is broadly applicable to clinical populations who may benefit from tailored neuromodulatory interventions designed to improve communication or related cognitive functions. The research is relevant to the NIA’s goal to develop effective interventions to maintain health, well-being, and function and reduce the burden of age-related diseases.